Integrating EHR and patient-generated health data for breast cancer risk assessment and decision support in a diverse multiethnic population

While breast cancer (BC) mortality has declined, this decline has begun to plateau, particularly among
racial/ethnic minorities. Women identified as high-risk for BC may benefit from chemoprevention, testing for BC
susceptibility genes, screening, and other personalized risk-reducing strategies; however, barriers exist including
the time required to conduct risk assessment of each woman in a population. Electronic health records (EHRs),
a common source for populating risk assessment models present challenges, including missing data, and data
type more accurate when provided by patients compared to EHRs. We previously extracted EHR data on age,
race/ethnicity, family history of BC, benign breast disease, and breast density to calculate BC risk according to
the Breast Cancer Surveillance Consortium (BCSC) model among 9,514 women. Comparing self-reported and
EHR data, more women with a first-degree family history of BC (14.6% vs. 4.4%) and benign breast biopsies
(21.3% vs. 11.3%) were identified with patient-reported data, but EHR data identified more women with atypia
or lobular carcinoma in situ (1.1% vs. 2.3%). The EHR had missing data on race/ethnicity for 26.8% of women
and on first-degree family history of BC for 87.2%. Opportunely, Fast Healthcare Interoperability Resources
(FHIR), application programming interfaces (APIs), and new legislation offer an elegant solution for automated
BC risk assessment that integrates both patient-generated health data and EHR data to harness the strengths
of each approach. In prior work, we developed the RealRisks decision aid using an iterative design process to
equitably maximize acceptability, and usability. RealRisks promotes understanding of BC risk and collects
patient-entered data to calculate BC risk according to the Gail model, BCSC, and BRCAPRO. When FHIR
became available, we updated RealRisks to automatically populate information for BC risk calculation from the
EHR, and designed a prototype interface that shows this data to patients with a request to review and modify
data before running the risk assessments. We recently conducted a feasibility study to demonstrate that EHR
data from FHIR could be incorporated into automated BC risk calculation. To increase the likelihood of
developing disseminatable and equitable strategies that integrate EHR and PGDH data for risk assessment and
personalized BC risk-reduction, the focus of this R21 is to refine and test our approach among diverse multiethnic
women. Our aims are: 1) conduct user evaluations to refine FHIR-enhanced RealRisks; 2) assess the effect of
the FHIR-enhanced RealRisks on patient activation, risk perception, and usability in a pilot study of multiethnic
high-risk women; and 3) identify multilevel barriers to implementing FHIR-enhanced RealRisks into clinical care.
Given the mortally associated with BC, focused efforts are needed to provide accurate risk assessment and
shared decision-making about risk-reducing strategies, especially in minority women who are more likely to be
diagnosed with advanced stage BC. If successful, the approach tested in this application may provide a roadmap
for broadly improving digital access to health data and reducing BC mortality in an equitable manner.

Public health relevance
PROJECT NARRATIVE Electronic health records (EHRs) are an increasingly common source for populating risk models, but whether used to populate validated risk assessment models or to de-facto build risk prediction models, EHR data presents several challenges. The integration of patient generated health data (PGHD) and EHR data can generate more accurate risk prediction models, advance personalized cancer prevention, improve digital access to health data in an equitable manner, and advance policy goals for PGHD and EHR interoperability.